Optimizing blood biopsy in cancers with low mutation burden and high structural complexity

PROJECT SUMMARY
Liquid biopsy is a non-invasive technique that can be used to help diagnose and monitor cancer. It is based on
the principle that tumor cells release small pieces of DNA and RNA into circulation. In several human cancers,
FDA-approved liquid biopsy tests are designed to look for common disease-associated mutations. These liquid
biopsy tests are most successful in tumors with a well-defined mutation landscape, such as lung and breast
cancer. However, looking for common mutations is less successful in structurally complex tumors with a lower
incidence of mutations, as is the case with many sarcomas, such as osteosarcoma (OS) and Ewing’s sarcoma.
Recent data indicate that mutation-independent liquid biopsy techniques, including assessment of circulating
DNA fragment size patterns and methylation status, can increase sensitivity of the assay and identify the tissue
of origin and histologic subtype of human cancers. Additionally, evidence now suggests that unique gene
expression and methylation signatures measured by liquid biopsy have the potential to act as a surrogate for
response to treatment and/or identify early emergence of treatment resistance. As such, there is potential for
using an advance liquid biopsy tool to inform patient-specific therapies more effectively, particularly in instances
where repeat imaging/tumor sampling is challenging. As such, the hypothesis underlying this proposal is that
gene expression and epigenetic metastatic signatures can be identified in RNA and DNA isolated from
plasma in canine OS and integrated using machine learning to improve the sensitivity of liquid biopsy.
It is further predicted that this improved liquid biopsy platform will be capable of identifying treatment
specific signatures reflective of response or resistance to therapy. We will use canine OS, which has a
structurally chaotic tumor genome, as a large animal disease model of human sarcomas. Using patient-matched
plasma samples from dogs with OS taken at multiple timepoints throughout treatment, we will evaluate cell-free
DNA and RNA using a comprehensive mutation-independent liquid biopsy assay. This will incorporate evaluation
multiple parameters, including cell-free DNA fragment sizes, methylation, and gene expression alterations and
use machine learning to optimize parameter integration. The liquid biopsy tool will be further validated for
detection of early disease progression in OS patients. Lastly, we will begin to dissect how drug exposure alters
disease-specific signatures in circulation. Ultimately, the tools and techniques developed from this work will have
broad applicability to both canine and human sarcomas, facilitating enhanced accuracy for cancer detection and
clinical decision-making. Importantly, the work outlined in this proposal provides a unique opportunity for
expansion of genomic skill sets in the context of translational medicine, thereby further supporting my
development as a successful independent clinician scientist.

Public health relevance
PROJECT NARRATIVE Liquid biopsy is a useful clinical diagnostic in cancers where known simple mutations can be identified and monitored, but current liquid biopsy techniques are less effective in cancers with few recurrent simple mutations, such as osteosarcoma (OS) and rhabdomyosarcoma. The studies in this proposal will comprehensively interrogate a mutation independent cell-free DNA and RNA (cfDNA/cfRNA) multi-parameter liquid biopsy approach in a spontaneous canine cancer model. This methodology aims to improve the sensitivity of cancer detection using liquid biopsy and enable rapid detection of early drug resistance across a wide range of genomically complex sarcomas.